A Digital Hemodynamic Twin for Right Ventricular Dysfunction

Project Summary
Clinical decisions based on hemodynamic data –time-varying measurements of pressure and volume in
the cardiovascular (CV) system– can be some of the most complex physicians will face. Yet they are consigned
to tackle these decisions with little more than a mental model of the patient. From deceptively simple questions
like whether a patient will respond to fluid resuscitation, to plainly challenging ones like whether the right ventricle
will tolerate placement of a left ventricular assist device, the physician must mentally reconstruct a patient’s
physiology from the shadows it casts in the form of clinical state measurements. Right ventricular (RV)
dysfunction, in particular, represents a large class of problems in cardiology whose management is widely seen
as challenging. This stems from inadequate RV monitoring tools and the challenge of gauging the RV’s
interactions with other cardiovascular subsystems. Given detailed hemodynamic measurements a physician
should be able to tap computational resources that would systematically infer a quantitative cardiovascular (CV)
model that gave rise to it, thereby characterizing the RV and its interactions. Computational models such as
these, which could be repeatedly updated as new sensor data stream in, are known as digital twins.
Here we propose to develop and validate a digital “hemodynamic” twin to aid the management of right
ventricular failure. Such a computational tool would allow the physician to explore a patient’s right ventricular
physiology in silico and to predict the effects and the limits of drug therapy. Specifically, we aim to solve the
inverse problem of system identification (SID) on real-world clinical data, both extending the computational tools
for hemodynamic SID and validating them on a large number of patients. We will focus on patients who are
susceptible to RV dysfunction, including outpatients with pulmonary hypertension and inpatients recovering from
cardiac surgery in an intensive care unit. The creation of a digital twin will require only data that are collected
using routine hemodynamic monitoring techniques that are widely available. We will test the fidelity of our SID
tools, use the digital twins to search for new subtypes of pulmonary hypertension and post-cardiac surgery
recovery, and determine the ability of newly identified cardiovascular parameters to predict patient outcomes.

Public health relevance
Project Narrative One of the heart’s two main pumping chambers, the right ventricle, sometimes fails and causes severe illness. The health of this heart chamber is difficult to monitor and treat, problems we aim to address with new ways to analyze a patient’s data. For patients with right heart failure our goal is to improve their chance of survival and shorten their time in intensive care.